Project Nurture Expansion Study

PROJECT SUMMARY
In the past 20 years, the United States (US) has seen a fourfold increase in the prevalence of maternal
substance use disorders during pregnancy. Substance use during pregnancy is associated with adverse
maternal and infant health outcomes. Numerous barriers impede the delivery of well-coordinated and high-
quality pregnancy and postpartum care for women with substance use disorder: lack of access to obstetrics
providers who are comfortable with providing medical care to women with substance use disorders; competing
demands from child welfare and necessary medical services; and limited availability of substance use disorder
treatment programs that allow children and provide parenting support resources. A coalition of maternity care
providers, substance use treatment agencies, state social service agencies, and Medicaid funding partners in
Oregon tested a care model called Project Nurture in three clinics in the Portland area in 2015. Project
Nurture combines maternity care, substance use disorder treatment, peer/doula support, and case
management in a single setting. Access to these services in a single care setting reduces barriers to care and
facilitates increased collaboration among providers, which creates a more supportive environment with realistic
expectations for mothers. Care is delivered in a non-judgmental and trauma-informed manner, which is
important given the high prevalence of stressful life events experienced by women with substance use
disorder. A peer-reviewed study found Project Nurture to be associated with reductions in child maltreatment
and placement of children in foster care, and increases in prenatal visits. Preliminary data from an independent
evaluator also suggest that Project Nurture may reduce preterm births, reduce intensive neonatal care, and
increase engagement in substance use disorder treatment. Oregon's Governor is expanding Project Nurture to
five rural and underserved counties. The objective of this study is to establish the empirical evidence needed to
replicate Project Nurture in other states. While preliminary findings suggest that Project Nurture improves
short- and longer-term maternal-infant outcomes, we propose further investigation to answer three critical
questions: (1) What are the key elements of Project Nurture associated with improved outcomes; (2) how can
these elements be implemented in rural and underserved settings; and (3) what is the effectiveness of Project
Nurture in rural regions and when mothers are engaged in methamphetamine and polysubstance use? Thus,
this study is designed to accomplish the following four aims: (1) Assess the effects of Project Nurture on
pregnancy, birth, neonatal, and child welfare outcomes; (2) Assess the effect of Project Nurture on health care
expenditures; (3) Describe implementation of Project Nurture; and (4) Identify critical elements of Project
Nurture and support replication and dissemination. This study will provide state, regional and organizational
leaders the information needed to replicate Project Nurture and create a safe and de-stigmatized care
environment for pregnant women living with substance use disorder.

Public health relevance
PROJECT NARRATIVE Substance use during pregnancy is associated with negative maternal and infant health outcomes and numerous barriers impede delivery of well-coordinated and high-quality pregnancy and postpartum care for pregnant women with substance use disorder. In a recent pilot study, Project Nurture, a clinical model designed to combine maternity care, substance use disorder treatment, peer / doula support and case management in a single setting, was associated with reductions in child maltreatment, placement of children in foster care, and increases in both prenatal visits and maternal lengths-of-stay in the hospital. This proposal leverages Oregon's expansion of Project Nurture to five rural / frontier and underserved counties, offering an ideal opportunity to assess the effectiveness of this promising clinical and to identify how it is implemented in order to foster replication to other regions and states.